2021 Physiology in Focus: The Role of Sex Hormones, Genetics and Gender in Physiology & Medicine

2021 Physiology in Focus: The Role of Sex Hormones, Genetics and Gender in Physiology & Medicine Project Summary/Abstract The purpose of this proposal is to seek support for the virtual APS Conference entitled “Physiology in Focus: The Role of Sex Hormones, Genetics and Gender in Physiology & Medicine” scheduled for September 28 – October 1, 2021 and was last held in 2018. The objective of this conference is to gather a critical mass of expert clinical and basic researchers with interests in the role of sex hormones, sex chromosomes, and gender in a variety of physiological and pathophysiological conditions. The conference will bring together nationally and internationally renowned scientists to exchange ideas, develop scientific relationships, and promote collaboration in a virtual platform. The meeting will have a strong emphasis on trainee involvement with activities at multiple levels, including designated trainee sessions and posters. The program will be organized into five distinct modules in biomedical sex differences research: neurophysiology, cardiovascular physiology and metabolic science, aging, gastrointestinal and renal physiology, and immunology. Ample time for poster sessions, workshops and planned activities will allow for in-depth discussions among trainees, young scientists and established investigators.

Public health relevance
2021 Physiology in Focus: The Role of Sex Hormones, Genetics and Gender in Physiology & Medicine - Project Narrative The purpose of this proposal is to seek support for the virtual APS Conference entitled “2021 Physiology in Focus: The Role of Sex Hormones, Genetics and Gender in Physiology & Medicine ” scheduled for September 28 - October 1, 2021. It is critical that we improve our collective understanding of how differences in male and female physiology and genetics contribute to health outcomes and disease by exchanging scientific ideas from an organismal to molecular perspectives and the associated underlying mechanisms. The meeting will have a strong focus on how sex differences contributes to overall health, with an emphasis on applied outcomes across a wide spectrum of organs/tissues (brain, cardiovascular system, lungs, gut, immune system) and populations (young and old adults, pregnant women).